Application of Gabriella Miller Kids First Pediatric Research Data to a Predictive Model of Neuroblastoma

Project Summary
There is currently no diagnostic tool to accurately predict pediatric neuroblastoma disease outcome that is
based on the mechanistic nature of the disease and genomic information of a child’s tumor. Neuroblastoma is
a solid, cancerous tumor of the sympathetic nervous system (SNS) that accounts for half of all cancers in
infants younger than 1 year. Uncertainties in the trajectory of disease progression has led to aggressive
radiation and chemotherapy treatments that often result in long-term developmental disabilities for children.
Determination of the critical drivers of neuroblastoma initiation and assessment of their interactions for an
individual child would help target chemotherapy and limit over-treatment, possibly resulting in an increased
quality of life and infant survival.
Our solution to this problem is to develop a predictive artificial intelligence algorithm (PredictNeuroB) and use
genomic input from a child’s tumor to test its predictive strengths to predict disease progression, identify critical
disease drivers and compare results to current clinical statistical-based algorithms. PredictNeuroB is based on
the network interactions of receptor tyrosine kinase (RTK) developmental signals and is supported by our
discovery of a critical role for trkB and its ligand brain-derived neurotrophic factor (BDNF) during SNS
development. Our published model’s prediction of early stage neuroblastoma (for infants 0-2yrs old) using
genomic information of 77 children is more accurate than any current clinical prognostic (Kasemeier-Kulesa et
al., 2018). In this study, we propose to strengthen the predictive capability of our model for a broader class of
patient data (age, stage of disease, chromosome status, MYCN amplification) by applying Gabriella Miller Kids
First neuroblastoma databases. Further, we will perform in silico perturbations of the algorithm to determine
critical drivers capable of altering neuroblastoma outcome states. At the conclusion of our study, by using a
larger set of patient-derived data with associated clinical and disease outcome information, we expect our
PredictNeuroB model will prove highly predictive for a broad class of neuroblastoma patients and support
clinical decision making in disease treatment and targeted drug therapies.

Public health relevance
Project Narrative Neuroblastoma accounts for half of all childhood cancers in infants younger than 1 year, yet there is no diagnostic tool to accurately predict disease progression and outcome. Our solution to this problem is to develop a predictive artificial intelligence algorithm (PredictNeuroB) that is based on the developmental signaling network from which neuroblastoma originates and test its capability to more precisely predict disease outcome using a child’s genomic information as input. By leveraging the information in Gabriella Miller Kids First databases we will test PredictNeuroB for a broader class of children than available in published academic data, resulting in a precise and personalized prognostic tool with the possibility to increase infant quality of life and survival by limiting over-treatment and targeting chemotherapy.